NIDCD T32 Interdisciplinary Training Program in Hearing Research

Project Summary
Progress towards understanding mechanisms of hearing, and the treatment of hearing deficits, requires an
integrated effort from multiple disciplines. The Center for Hearing Research (CHR) at the University of
California, Irvine (UCI) maintains an interdisciplinary training program that takes advantage of the breadth and
depth of hearing research at UCI to train new scientists broadly across multiple disciplines and deeply in one.
The 21 training faculty in CHR span six departments in five Schools (primary appointments in Biological
Sciences, Medicine, Social Sciences and Education; joint appointments in Engineering) with research interests
that cover a broad range of levels (genes, molecules, cells, systems and behavior) and experimental
approaches (cell and molecular biology, neurophysiology, psychoacoustics, computation, human imaging,
human learning, medical device engineering). Thus, CHR is ideally positioned to offer interdisciplinary training.
We request support for three predoctoral students and two postdoctoral researchers including medical
residents. The didactic core of the training program is a course in Auditory Neuroscience, which covers the
auditory system from cells to psychoacoustics, cochlea to cortex, and basic to clinical sciences. Mandatory
features of the training program that encourage interdisciplinary interactions are participation in all CHR
activities (e.g., seminar series, journal club and annual conferences), presentations to scientifically diverse
audiences, and regular meetings with basic and clinical scientists. The normal period of support for trainees is
two years. Predoctoral trainees normally enter the program in their second year of graduate study and are
required to take a course on grant writing and prepare an NRSA proposal. The program is managed by the
Program Director and an Executive Committee, and will foster development of trainees’ intellectual, technical
and professional skills needed to pursue successful careers in hearing research.

Public health relevance
Project Narrative To fully understand how we hear, and develop effective treatments for hearing deficits, requires knowledge of multiple disciplines, such as biology, medicine and engineering. This program trains junior scientists to be experts in one discipline and familiar with several, so that they are able to focus the tools and techniques of multiple disciplines on the problems to be solved.